RESEARCH RESOURCE OF BB/WOR DIABETIC RATS

Studies on the etiology, pathology and potential therapeutic interventions for Insulin Dependent Diabetes Mellitus (IDDM) have been greatly assisted by the availability of a suitable animal model, the BB-Wor diabetic rat. This model has been difficult to establish and produce. The project objectives of this contract are to continue a centralized and stable source of supply the BB-Wor diabetic rat, to develop a cost-reimbursement system for the distribution of these animals, and to continue the development of genetically homogeneous familial lines with and without the diabetic defect.